Academic-Industrial Partnership for Non-invasive Barrett's Esophagus Detection

Barrett’s esophagus (BE) is the dangerous obligate premalignant precursor lesion of esophageal
adenocarcinoma (EAC), one of the most rapidly increasing and lethal malignancies in the United States and
Europe(3). EAC is rarely detected before it becomes invasive and untreatable, and 95% of EACs develop in
patients not previously diagnosed with BE(19)(20). Patients diagnosed with BE, in contrast, have an excellent
prognosis, since neoplasia is detected very early by periodic endoscopic surveillance. There is, however, no
currently available screening test for BE. Clinical translation of minimally invasive, low-cost biomarker-based
approaches to BE diagnosis will improve early EAC detection and increase overall survival. By combining our
swallowable, retrievable esophageal sample collection sponge (EsophaCapTM) manufactured by our industrial
partner, Capnostics, with our patented BE DNA methylation markers and our enhanced processing
technique, Methylation-On-Beads (MOB) to maximize extraction and bisulfite conversion of DNA; and by
establishing this assay in the CLIA-compliant laboratory of our industrial partner, MyGenetx, we can now make
this assay widely available. Preliminary data demonstrate high diagnostic accuracy of our sponge-based
biomarker test for BE. We will apply this strategy by pursuing the following Specific Aims: Aim 1. To analytically
validate our EsophaCapTM-based BE diagnostic assay. Aim 1a. First, using technical replicate EsophaCapTM
specimens from 42 newly recruited BE patients and 42 non-BE controls, we will confirm the accuracy,
robustness, and reliability of our BE diagnostic assay. Preliminary results in this context are also encouraging
(see Table 2, Technical replicates). Aim 1b. Next, in these same 42 patients with known BE vs. 42 controls
without BE, we will establish analytical concordance of EsophaCapTM-based data with matched tissue biopsy
sample data. Aim 2. To conduct a pilot study to validate a multivariate model for EsophaCapTM-based
diagnosis of BE. Based on our already-collected EsophaCapTM-derived specimen training dataset (see Fig. 5),
we have constructed a 3-marker prediction model for BE (Fig. 6). We will apply this model and the chosen cut-
off threshold to a newly collected set of 50 untested samples (independent of the Aim 1 samples). Aim 3. To
prospectively test the combined sponge-methylation biomarker strategy in a test set cohort of BE
patients vs. controls. Our assay will be performed in EsophaCapTM-derived samples from a prospectively-
collected cohort of 80 BE patients and 240 controls. The multivariate model validated in Aim 2 will be applied to
this test set of large patient population. Aim 4. To industrialize our EsophaCapTM assay protocol. In parallel
and simultaneously with Aims 1-3, we will establish all steps in our MOB-based DNA extraction, bisulfite
modification and quantitative methylation-specific PCR (qMSP) protocol in the CLIA-compliant laboratory at
MyGenetx. Assays performed in Aim 3 will be repeated by obtaining repeat sponges from the same patients,
this time in the CLIA lab, and checked for accuracy by comparison to Aim 3 results.

Public health relevance
This application proposes a plan to industrialize our minimally invasive strategy to detect Barrett's esophagus (BE). This strategy comprises a swallowable, retrievable esophageal sponge (EsophaCapTM), coupled with our BE methylation biomarker panel and a nano-analytic method known as methylation on beads (MOB), which will be analytically and clinically validated and established in the CLIA lab of our industrial partner, MyGenetx.